The ECOG-ACRIN SUPPORT Trial: Multilevel Intervention to Improve Diverse Enrollment in Cancer Clinical Trials

ABSTRACT National Cancer Institute (NCI) supported clinical trials (CTs) are key drivers of innovations in cancer care; however limited participation in NCI-supported CTs reduces reach and thus some are not able to fully benefit from cutting edge treatments and precision medicine. CT participation continues to fall short and the multitude of structural, clinical, physician, and patient barriers warrant multilevel interventions to enhance referral and enrollment to NCI-supported CTs. The ECOG-ACRIN Cancer Research Group (EA), as an NCORP Research Base, has engaged community providers and researchers through a robust research portfolio that spans Cancer Control, Cancer Prevention, and Cancer Care Delivery. We propose to leverage the collective resources of the EA, our team’s decades of work on improving participation in clinical trials, and our foundational work in patient navigation and CT research literacy tools to create and evaluate an ECOG-ACRIN Trial SUPPORT Toolkit (SUPPORT intervention) that aims to improve referral and enrollment in active NCI-supported therapeutic trials. The multilevel EA SUPPORT intervention consists of a CT research literacy tool and CT Resource Navigators who will interface with patients, providers, and community oncology site staff to improve referral and enrollment to CTs.

Public health relevance
PROJECT NARRATIVE Clinical trials (CT) participation continues to fall short, and the multitude of structural, clinical, physician, and patient barriers call for multilevel interventions to enhance referral and enrollment to National Cancer Institute (NCI)-supported CTs. Building on the extensive resources of the ECOG-ACRIN Cancer Research Group (EA) and our team’s expertise in patient navigation research, community engagement, clinical trials enrollment, and implementation science, we will develop a multilevel EA SUPPORT intervention (consisting of a CT Research Literacy Tool and CT Resource Navigators) to increase referral and enrollment of cancer patients to NCI-supported CTs.